Reducing Polypharmacy and Fall Risk for Multi-Morbid Adults with Chronic Obstructive Pulmonary Disease

Project summary
Chronic obstructive pulmonary disease (COPD) is a leading cause of morbidity and mortality in the US and
results in significant reduction in quality of life and functional status. Patients with COPD are 55 times more
likely to fall than patients without COPD, putting these patients at high risk of fall-related injuries and further
decrements in quality of life and health. This study will tackle the common and important problem of use of fall-
risk increasing drugs (FRIDs) among patients with COPD. This will be achieved by implementing and
evaluating a pharmacist-led deprescribing intervention to reduce FRIDs use among community-dwelling, multi-
morbid adults with COPD. The central hypothesis of this proposal is that poor communication and limited
shared decision making between prescribers, patients, and patient caregivers represent modifiable barriers to
deprescribing. Once these barriers are addressed, prescribers, patients and caregivers will be amenable to
informed deprescribing as part of this targeted intervention. In Specific Aim 1, I will use a national database to
assess commonly used FRIDs among patients with COPD, identifying FRID types and combinations
associated with the highest fall risk. In Specific Aim 2, I will interview patients with COPD, their family
caregivers, and clinicians (primary care providers, pulmonologists, pharmacists) to elicit barriers, facilitators
and key strategies to deprescribing FRIDs and enhancing shared decision making between clinicians and
patients. In Specific Aim 3, I will conduct a pilot randomized trial, testing a pharmacist-led deprescribing
intervention, adapted using findings from Specific Aims 1 and 2. I will evaluate the feasibility, acceptability and
appropriateness of the intervention using semi-structured interviews and structured questionnaires. I will also
explore the preliminary efficacy of the intervention compared to usual care for the primary outcome of FRID
discontinuation. This pilot trial will provide preliminary data for a future R01-funded hybrid effectiveness-
implementation trial. This research is innovative in that: 1) no prior study has evaluated an intervention to
facilitate deprescribing FRIDs among patients with COPD; 2) this intervention includes family caregivers, who
provide informal medication management to patients; and 3) this project uses a pulmonary clinic-based
pharmacist as a conduit to improve communication and shared decision making among patients, caregivers
and clinicians. My learning objectives are to learn a) advanced statistical methods to evaluate fall risk among
patients with COPD, b) training on COPD therapeutics and fall risk assessment, c) behavioral intervention
optimization, adaptation and assessment, and d) behavioral clinical trials design for future intervention trials.
My long-term career goals are to evaluate and disseminate evidence-based interventions to improve
medication management and healthcare delivery for multi-morbid adults with COPD.

Public health relevance
Project narrative Although the majority of patients with chronic obstructive pulmonary disease (COPD) take fall-risk increasing drugs (FRIDs) and falls are a significant source of morbidity and mortality for patients, there are to date no interventions that tailor and target deprescribing efforts for this population. This K23 application will adapt and test a novel pharmacist-led deprescribing intervention for patients with COPD, using qualitative data from patients, family caregivers and prescribers to guide the adaptation, delivery, and evaluation of a pharmacist-led deprescribing intervention. This research will provide data on how to reduce medication-related harm to improve quality of life and reduce medication-associated morbidity and mortality for patients with COPD.